40th National Neurotrauma Society (NNS) Annual Symposium 2023 - Celebrating the Landmarks of Neurotrauma

Abstract
Neurotrauma, such as traumatic brain injury (TBI) and spinal cord injury (SCI), affects millions of people
worldwide yearly. The National Neurotrauma Society (NNS) is committed to the promotion of neurotrauma
research by enhancing communication, providing a forum for scientific exchange, and increasing national and
international support for neurotrauma research and clinical advances. Every year, the society holds a
symposium to meet this goal and provide a forum for researchers, clinicians, and trainees from around the
world to meet and discuss the latest breakthroughs to improve the lives of individuals living with TBI and SCI
related disability. The 40th Annual Neurotrauma Symposium, jointly sponsored by the NNS and the American
Association of Neurological Surgeons/Congress of Neurological Surgeons (AANS/CNS) Joint Section on
Neurotrauma and Critical Care will be held in Austin, TX, June 25- June 28, 2023. As the 40th anniversary of
the symposium and 35th anniversary of the founding of the NNS as an independent society, this meeting will
focus on showcasing the latest ground-breaking achievements in the neurotrauma field while celebrating the
foundational research that established the field and continues to influence emerging knowledge and tools to
improve neurotrauma research and clinical care. Broad objectives of the Symposium are to update attendees
on current and timely topics in basic and clinical neurotrauma, to facilitate exchange of information among
participants and to build new scientific collaborations, with a foundation in rigor, reproducibility, transparency
and translation. A centerpiece of the Symposium is to foster participation and active engagement of trainees
and young investigators, through our travel awards, poster competition, data blitz oral presentations, workshops
and activities from the Training, Education and Mentoring (TEAM) Committee. NIH funding for previous NNS
Symposiums has provided invaluable support for scientific sessions and for enhancing our ability to reach
graduate students, postdoctoral researchers, residents, and young investigators. NIH support helps the NNS
to provide travel awards to continue to promote attendance for trainees, including underrepresented minorities
(URM), women, and persons with disabilities. This application seeks funding to support 25 pre-and-postdoctoral
trainees to present their ongoing work, attend scientific sessions, and to network with peers and faculty. Of the
25 trainees, 5 will be URM and persons with disabilities as the society strives to continue to promote and retain
diversity. In addition, we request support for programming for trainee and young investigator development
sessions, sponsored by the TEAM Committee. Finally, we request support to continue our Local Diversity
Scholars Program (LDSP), successfully initiated in 2022, which provides support for undergraduate and
graduate students from local Historical Back Colleges & Universities (HBCU) in Austin to attend the NNS
Symposium, be paired with a NNS faculty mentor, and receive training to promote interest in careers in
neurotrauma and neuroscience research.

Public health relevance
Project Narrative Traumatic brain injury (TBI) and spinal cord injury (SCI) are a major public health burden that often lead to lifelong impairment and disability. The National Neurotrauma Society (NNS), largely through its annual Symposium, is a critical translational research resource for sharing the latest advances in the neurotrauma field, with the ultimate goal of improving the treatments available to patients. Ongoing support for this annual meeting ensures a major national investment in advancing and innovating neurotrauma research and in the career development of trainees, with a focus on opportunities for increasing and retaining diversity in trainees and faculty in the neurotrauma field.